Functional Genomics Core

The objective of the Functional Genomics Core is to provide state of the art experiment planning, sample preparation, quality assessment, microarray, DNA sequencing, and data analysis services to DRC members.